A Dyadic Approach to Improve Sleep and Well-Being Among Persons with Alzheimer's Disease and Their Caregivers

Project Summary/Abstract
Poor sleep is very common in persons with Alzheimer’s disease and related dementias (ADRD) and
their caregivers. It is significantly associated with adverse mental and physical health outcomes and well-being
in both members of the group. Unmanaged poor sleep will further impact the quality of care that the caregivers
provide for the patients. This suggests a critical need of sleep management in this vulnerable population.
Unfortunately, an intervention addressing sleep problems of both members of the dyad simultaneously is
lacking, particularly using the behavioral strategies that have been effective in other groups. Effects of sleep
intervention programs in different delivery modalities are also unknown in this group.
The current proposal aims to examine the efficacy of a dyadic sleep intervention program for ADRD
patients and their caregivers, that is built upon PI’s prior work. We propose a 3-arm randomized controlled trial
design (Stage II), including both in-person (n=70 dyads) and telehealth (n=70 dyads) delivery of the
intervention, compared to in-person sleep education control (n=70 dyads). The dyadic intervention is a 5-week,
manual-based program, which incorporates key components of cognitive behavioral therapy for insomnia, daily
light exposure and walking, and a problem-solving approach for ADRD-related problematic nighttime behaviors
and other caregiving challenges. All intervention sessions will be delivered by a sleep educator. Primary
outcomes include subjective and objective sleep quality of the dyads. Secondary outcomes include the
patients’ dementia-related behaviors and quality of life, and the caregivers’ burden, depression, and perceived
health. We will also explore effects of the dyadic sleep program on inflammatory markers among caregivers.
All outcomes will be measured at baseline, post-intervention (i.e., immediately after the last session of the
intervention), and 6-month after the last session. Both superior (both in-person and telehealth interventions
versus control) and non-inferior effects (in-person versus telehealth intervention) will be tested.
A unique aspect of the proposed work is that the program is tailored to address sleep problems of both
patients and caregivers, and includes inflammatory biomarkers to evaluate a key mechanism of intervention
benefits that can be further explored in future research. The knowledge gained from this study has the potential
to improve the lives of ADRD patients and their caregivers. Our dyadic sleep intervention can be disseminated
to multiple communities serving ADRD patients and/or caregivers, including those that lack access to
traditional in-person sleep treatment. The intervention manual can also be used to train health professionals
and staff in various types of community programs.

Public health relevance
Project Narrative Poor sleep among persons with Alzheimer’s disease and related dementias (ADRD) and their caregivers negatively impacts both of their health outcomes and caregivers’ ability to keep their loved ones at home. This proposal will test efficacy of an innovative sleep intervention program (in-person and telehealth) that targets both members of the dyad simultaneously in a randomized controlled trial. Improved sleep in persons with ADRD and their caregivers may improve health and quality of life, and prevent or delay admission of ADRD patients to institutional settings, potentially leading to decreased healthcare costs.